Molecular and cellular exploration of striatal astrocytes in aging

Abstract
As part of the basal ganglia circuitry, the striatum is a large, evolutionarily conserved brain nucleus that serves
multiple essential functions throughout the lifespan, including precise information encoding necessary for a range
of motor behaviors and skills. Normal aging disrupts striatal function, resulting in degradation of motor learning
and susceptibility to age-related neurodegenerative diseases such as Huntington’s disease (HD) and
Parkinson’s disease (PD). Glial cells are abundant within the striatum and are known to exhibit age-related
decline. For example, human single-nucleus RNA sequencing (snRNAseq) of several brain regions, including
the striatum, demonstrated that age degrades the molecular signatures of glia more than those of neurons.
Astrocytes are a type of glia and are found throughout the mammalian brain, interacting spatially and functionally
with neurons, blood vessels, and other glia. They serve multiple homeostatic and active functions and are
involved in neuroinflammation, synapse formation, removal, and regulation. A long standing and open question
concerns how astrocytes change during aging. One recent study employing postmortem human tissue found
synaptic gene expression changes are coordinated in neurons and astrocytes, and another showed astrocytes
lose their complex morphology with aging. In mice, several transcriptomic approaches show that glia display
more pronounced changes in gene expression and density than neurons with age. Gene expression analyses
of astrocytes across several brain regions of mice also demonstrated marked age-induced shifts in their
transcriptomes, with separable patterns of decline that were apparent within individual brain regions. However,
the striatum was not included in the evaluations and consequently despite progress how striatal astrocytes
change with age in mice remains unknown. Since normal brain aging is a multicellular process, we seek to
provide astrocyte-specific proteomic, transcriptomic, and functional data for how astrocytes change with age in
the striatum of mice. The availability of these data, along with already available postmortem human gene
expression studies, will permit specific mechanistic hypotheses in mouse models to ultimately aid in
understanding normal aging and aging-related diseases such as HD and PD that affect the basal ganglia. We
will test the hypothesis that striatal astrocytes undergo molecular, cellular, and functional changes with
aging that can be assessed rigorously with state-of-the-art methods and understood in molecular terms.
Specific Aim 1 will determine striatal astrocyte subproteomes and transcriptome in 18-month-old mice in relation
to 2-month-old mice. Specific Aim 2 will evaluate functional and cellular properties of striatal astrocytes in 2- and
18-month-old mice. Our exploratory studies could have widespread applications in striatal and age-related
astrocyte research, enabling development of hypothesis driven mechanistic studies in follow up R01 applications.

Public health relevance
Relevance statement Mental illness affects an estimated 13% of adults 60 years of age and above in the US. Decades of clinical experience demonstrates that mental disorders in older adults have differences in symptomology and response to treatments, but our understanding of the molecular changes in the aging brain that underlie these clinical phenomena has lagged even as the aging population has grown. We will provide new data for how astrocytes change in the aging striatum, a critical brain nucleus involved in multiple brain disorders.